The effect of gonadotropin pathway genetic variation on PCOS pathogenesis

PROJECT SUMMARY
Polycystic ovary syndrome (PCOS) is a common, complex, and heritable endocrinopathy, affecting 6-20% of
reproductive age women. PCOS is defined by elevated androgens, irregular or absent periods, and polycystic
ovarian morphology and is diagnosed by the presence of two or more of these reproductive phenotypes. There
are many interacting physiological pathways that contribute to PCOS pathogenesis, including insulin resistance,
ovulatory dysfunction, and gonadotropin signaling dysfunction. Due to the multifactorial nature of this disorder,
current clinical interventions are variably effective and do not address the underlying causes of PCOS. Twin and
family studies have shown PCOS to be highly heritable. Furthermore, genome-wide association studies (GWAS)
have implicated genes involved in insulin resistance, diabetes, ovulation, and gonadotropin signaling. Genetic
factors, therefore, are likely contribute to the heterogeneity of PCOS. With the advent of Next Generation
Sequencing (NGS) it is now feasible to comprehensively identify genetic variation mapping to a genome, gene,
or molecular pathway. Our long-term objective is to identify genetic drivers of PCOS. The gonadotropin
hormones, follicle stimulating hormone (FSH) and luteinizing hormone (LH), are part of the neuroendocrine
signaling network that direct follicle development and overall ovarian health. Reproductive neuroendocrine
dysfunction is a major pathophysiological component of PCOS. Women with PCOS have an imbalance of
LH:FSH ratio resulting in hyperandrogenism and oligo/anovulation—two cardinal characteristics of PCOS.
Although gonadotropin genes have long been implicated in PCOS pathogenesis, no causal variants have yet
been identified. Given the physiological relevance of gonadotropin signaling dysfunction and genetic implications
of gonadotropin genes in PCOS, our hypothesis is that genetic variation in gonadotropin genes contributes to
PCOS pathogenesis. Therefore, our goal is to elucidate the molecular mechanisms of gonadotropin signaling
dysfunction in PCOS. In this study, we will evaluate the genetic burden of potentially pathogenic variants (PPVs)
in the gonadotropin signaling pathway in women with PCOS using two independent PCOS cohorts (Aim 1).
Furthermore, we will elucidate the molecular mechanisms by which these pathogenic variants cause
gonadotropin signaling dysfunction through functional studies (Aim 2). Successful implementation of these aims
will reveal the extent to which gonadotropin dysfunction is an underlying cause of PCOS, which members of the
gonadotropin signaling pathway are impaired in PCOS, and how pathogenic variants in this pathway impair
gonadotropin signaling at the cellular level.

Public health relevance
PROJECT NARRATIVE PCOS, one of the most common endocrine disorders among reproductive age women, has heterogenous pathophysiology and unknown etiology. Underlying genetic variation in patients contributes to the PCOS heterogeneity, and previous genetic studies have implicated gonadotropin gene variants in PCOS pathogenesis. In this proposal, we apply genetic and molecular approaches to identify potentially pathogenic variants in the gonadotropin signaling pathway and elucidate the molecular mechanisms of gonadotropin signaling dysfunction in PCOS.